Effects of Continuous versus Cyclic Oral Contraceptives on Mammary Tumor Growth

DESCRIPTION (provided by applicant): There is no question that breast cancer susceptibility is strongly correlated with lifelong exposure to estrogen and progesterone (E+P). Extension of E+P exposure using a widely employed hormone replacement therapy (HRT) increased breast cancer risk in postmenopausal women. Oral contraceptive (OC) use, in a manner similar to HRT, is an example of a widely used hormonal regimen with the potential to impact breast cancer chemoprevention in a huge population. Unlike HRT, OC are used over a large expanse of a lifetime, sometimes initiated as early as puberty, to control fertility and menstrual side effects. With the recent advent of the continuous dosing regimen, in which the hormone withdrawal period is eliminated, women have the option to undergo months or years of continuous hormonal exposure with no remodeling of the breast or uterus that normally accompanies cyclic dosing regimens. Based on the ability of OC to eliminate menstruation and accompanying side effects, it is not surprising that many of the ~21% of adult women in the US who are current users of OC have begun to shift to a continuous regimen. It is critical, therefore, to determine whether continuous exposure to OC carries a significant risk to increase breast cancer. Although we might predict an increased risk (based on the risks from HRT), cycling women experience two types of tissue responses that do not occur in menopausal women: (i) cycles of epithelial and stromal vascular (angiogenic) proliferation in response to hormones, and (ii) cycles of apoptosis and glandular and stromal vascular regression. These two observations suggest two alternate potential outcomes of continuous OC dosing: (i) If hormone-dependent epithelial and angiogenic proliferation is critical to breast cancer risk, we predict that continuos OC use will increase breast cancer risk; (ii) Alternately, if the glandular and stromal vascular regression and remodeling in response to hormone withdrawal contribute to breast cancer risk (as has been proposed for hormone withdrawal during post-lactational involution), then continuous dosing may decrease breast cancer risk. This proposal is designed to test these two alternate hypotheses. Aim 1 will compare the ability of cyclic (3 days on, 1 day off) versus continuous dosing +/- OC to alter spontaneous tumor development, progression, and metastases in the FVB-MMTV-Her-2/Neu model of spontaneous mammary tumorigenesis. Aim 2 will compare the ability of cyclic versus continuous dosing +/- OC to alter the mammary tumor growth using the TM2H transplantable mouse mammary tumor cell line. Mammary tumors from different treatment groups will be compared for alterations in expression of ER, PR, and Her2/Neu, vascularity and proliferative and apoptotic indices. The primary outcome of these studies is to define the effects of continuous dosing of OC on primary and metastatic mammary tumor growth in two distinct mouse mammary tumor models, relative to no OC or cyclic dosing of OC.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many women currently using oral contraceptives are opting to switch from a regimen of cyclic dosing (three weeks on, one week of hormone withdrawal) to continuous dosing (with no hormone withdrawal period). The goal of the current proposal is to evaluate whether these two methods of dosing differ in contributing to breast cancer risk, as a result of two different outcomes: (i) continuous dosing could cause longer periods of sustained hormonal stimulation, thus potentially increasing breast cancer risk, or (ii) continuous dosing, by eliminating the hormone withdrawal period, could decrease breast cancer risk through decreased mammary gland remodeling and by the loss of time during which progesterone sensitivity is "re-set". These alternate outcomes will be evaluated using two complementary mouse models: (i) the spontaneous mammary tumor model of transgenic FVB-MMTV-Her2/neu mice, and (ii) a transplantation model using BALB/C mice receiving the syngeneic TM2H mouse mammary tumor cell line. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Oral contraceptives (OC) represent a prevalent drug regimen which has unprecedented success in chemoprevention of endometrial and ovarian cancers. However, OC have shown no efficacy in preventing breast cancer, and may actually increase risk: a meta-analysis from epidemiological studies of 53,297 breast cancer cases and 100,239 controls indicated that breast cancer risk was increased by 25% in current OC users, by 16% in the 4 years after discontinuation, and by 7% in the period 5-9 years after discontinuation (8). For current users, risk further increased when age at first OC administration was before age 20, suggesting that soon after onset of puberty, susceptibility to OC-dependent breast cancer risk is increased (8). It is important to understand that these risks are only described OC cyclic dosing, i.e. three weeks on, followed by one week hormone withdrawal. However, a new trend in OC dosing is coming into vogue, which may have unexpected impacts on OC-associated breast cancer risk. The most commonly prescribed OCs have 21 active pills followed by 7 placebo pills in a 28-day cycle with a regular withdrawal bleed during the placebo week. It is estimated that ~18% of US women between 15-44 years of age currently use OC (27). When surveyed, 58% of US women said they would prefer decreased menstrual frequency via extended or continuous OC use [reviewed in (34)]. Given the medically accepted use of continuous active OC to avoid menstruation, extended active pill OC use is increasing, particularly including among very young women. It is critical, therefore, to determine whether this change to more continuous active OC dosing is likely to result in an altered risk of breast cancer. Notably, the long-term impact of continuous OC use, initiated at a very young age on breast cancer risk has not been determined. In this study, we will address this critical concern by testing two alternate hypotheses: (I) Continuous exposure of the breast epithelium and vasculature to estrogen + progesterone (E+P)-with its associated breast cell proliferation will further increase breast cancer risk; (II) Continuous exposure of the breast epithelium and vasculature to E+P, by removal of the regression period of diestrus II (equivalent to the human menstruation hormonal withdrawal period occurring in the late luteal and early follicular phase of the cycle) will decrease breast cancer risk compared to the usual cyclical OC regimen and possibly to normal cycling. These hypotheses will be tested in the following Specific Aims: Aim 1: To determine the effects of continuous hormonal exposure on spontaneous mammary tumor incidence. FVB-MMTV-Her-2/Neu mice will be exposed to a regimen of continuous versus cyclic (three days active pill, one day off) dosing with an active OC from day 50 (puberty) until day 180 (130 days of treatment) placebo. Mice will be tracked serially until day 365 of age (or until tumor size exceeds 1 cm in longest diameter) for tumor latency, multiplicity and burden. Contralateral mammary gland, if tumor-free, will be taken at sacrifice for whole mount analysis of epithelial density. Tumors and adjacent glandular tissue will be assessed for angiogenesis and proliferative/apoptotic indices, as well as expression of ER, PR and Her2. Metastasis to the lung will be assessed by histopathologic analysis of serial sections. Because this mammary tumor model expresses the transgene driven by a hormone-sensitive promoter, we will perform a mathematical adjustment for "hormonal age" to compensate for increased time of continuous exposure in a given experimental period. A control group receiving only placebo pills will be included for pair-wise comparisons. Aim 2: To characterize the ability of continuous OC exposure to alter transplanted mammary tumor growth. BALB/c mice will be exposed to continuous versus cyclic regimens of OC from day 50 of age to day 180, and syngeneic TM2H tumor cells will be injected orthotopically at day 78 of age. Mice will be serially tracked by palpation, as in Aim 1, until day 365 of age, or until tumor size exceeds 1 cm in longest diameter. Subsequent tumor latency, burden, growth kinetics and metastasis will be compared between these two groups of mice compared to a control group (no OC). After sacrifice, tumors and adjacent glandular tissue will be assessed for vascular density, proliferative/apoptotic indices. Whole mounts of contralateral tumor-free mammary gland will be assessed for epithelial density. The impact of these studies on human breast cancer will be several-fold: i. To identify whether cyclic versus continuous dosing of OC alters mammary tumor incidence in a spontaneous mouse model that mimics Her2/neu positive human breast cancer; ii. To determine if cyclic versus continuous dosing alters the stroma to enhance or suppress establishment, latency and growth of tumors (using the transplantable TM2H model); iii. To define whether these OC dosage regimens alter the rate of metastases. iv. To define whether OC use correlates with vascular or mammary epithelial density, proliferation, and apoptosis.